Genetic and biochemical dissection of mammalian pachytene piRNA biogenesis.

PROJECT SUMMARY
Pachytene piRNAs are a population of PIWI-interacting RNAs unique to mammals that
are highly expressed in meiotic germ cells. Disruption in pachytene piRNA production
results in spermatogenic failure and infertility in both mice and humans. Pachytene
piRNAs are generated from long piRNA precursors through cleavage by a piRNA
processing machinery near the mitochondrial surface and loaded onto PIWI proteins.
Our recent published data revealed the importance of piRNA biogenesis factors and
mitochondrial surface-based processing machinery in controlling pachytene piRNA
maturation to promote spermatogenesis. However, the molecular mechanism by which
pachytene piRNAs are produced and their precise functions remain elusive. In this
proposal, we will combine mouse genetics and biochemistry to tackle three key
questions that are fundamental to understanding pachytene piRNA biogenesis and
function in germ cells: 1) How do regulatory motifs direct PIWI proteins to engage in
piRNA biogenesis to promote spermatogenesis? 2) How does the mitochondrial
membrane-based piRNA processing machinery dynamically operate? 3) How do mature
PIWI/piRNAs exit the processing machinery for effector function? These studies will
provide novel insight into the organizing principle of the piRNA pathway and reveal new
mechanisms underlying mammalian pachytene piRNA biology important to normal germ
cell development, human fertility, and reproductive health.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) This project investigates the production mechanism of a class of small regulatory RNAs in mammalian male germ cells. The results of this study will help better understand the molecular function of small RNAs in sperm development and the genetic causes of male fertility disorders. It will also provide new knowledge for the future development of male contraceptives for human reproductive health.